SENSORS FOR WATER CONTAMINANT DETECTION AND MONITORING

ABSTRACT
Groundwater in Superfund sites is contaminated with a wide range of hazardous chemicals originating from
anthropogenic and natural sources. Individuals exposed to these chemicals through contaminated drinking water
can be subjected to adverse health effects. The YSRTP will focus on 1,4-dioxane (1,4-DX) and its co-occurring
contaminants: trichloroethylene (TCE), 1,1,1-trichloroethane (TCA), and 1,1-dichloroethane (DCA). To protect
drinking water supplies and human health, rapid approaches for the detection and monitoring of these
contaminants are crucial. The overall goal of this project is to develop sensors for 1,4-DX and its co-contaminants
with real-time monitoring via a wireless network. The project includes four specific aims: (1) developing and
characterizing biosensors for 1,4-DX detection and quantification, (2) developing and characterizing chemical
sensors for 1,4-DX co-occurring contaminants (TCE, TCA, and DCA), (3) 1,4-DX and co-contaminant detection
via portable vacuum gas chromatography, and (4) demonstrating detection in a distributed wireless sensor
network for contaminant monitoring. The main innovative aspects of the research include the following: (i)
developing the first sensor for detecting low, health relevant concentrations of 1,4-DX, by employing an
evolutionary selection process, an artificially antibody affinity maturation technique, and organometallic pre-
binding molecules; (ii) developing a chemical sensor that exploits the unique solubility-based selectivity of lipid
and block-copolymer bilayer vesicles for detecting TCE, DCA, and TCA as a proxy for 1,4-DX contamination;
and (iii) demonstrating the use of 1,4-DX sensors and adapted portable vacuum gas chromatographers in a
wireless sensor network (WSN) to enable responses to dynamic contamination and exposure events. The project
is well integrated with the overall YSRTP. The real time data of contaminant concentrations provided by the WSN
will be integrated Project 4 to improve remediation strategies and measure remediation effectiveness and help
inform the biomedical projects (Projects 1,2) on exposures for communities in the vicinity of the Superfund sites,
and inform the community—through the Community Engagement Core—on real-time concentrations of the
target contaminants in drinking water sources. The project will also be engaged with the Data Management &
Analysis Core (DMAC) to appropriately store and analyze all contaminant occurrence and concentration data
pursuant to the above project interactions and for assistance in the WSN to meet the stated measurement goals.

Public health relevance
NARRATIVE: RELEVANCE TO PUBLIC HEALTH Groundwater often serves as a source for drinking water supply. Near Superfund sites, groundwater can be contaminated with a wide range of chemicals. Individuals exposed to these hazardous chemicals through contaminated drinking water can be subjected to adverse health effects. Because current analytical methods to detect hazardous chemicals involve expensive and time-consuming laboratory analyses, monitoring public exposure necessitates development of new, rapid, low cost approaches to measure water contaminants. Sensor technologies and wireless sensor networks embedded in drinking water systems can provide rapid on-site detection and monitoring of target contaminants, thus enhancing the safety of drinking water and protecting human health.